Testing an Online Insomnia Intervention to Reduce Alcohol Use via Improved Sleep Among Heavy Drinkers

ABSTRACT
Alcohol use disorder (AUD) inflicts enormous physical, emotional, and financial burdens on the individual and
society at large. Insomnia, a public health crisis in its own right, is highly prevalent among individuals with
AUD. Both AUD and insomnia are particularly problematic in women, as women have a 40% higher insomnia
risk than men, and incidence of AUD is increasing among women at alarming rates. AUD and insomnia have a
bidirectional and feed-forward relationship, such that excessive alcohol consumption negatively impacts sleep,
and disrupted sleep contributes substantially to alcohol-related problems. Moreover, our preliminary data
suggests that this association may be particularly pronounced in women. Importantly, insomnia often precedes
problematic drinking in both adolescents and adults. As such, insomnia serves as a potential intervention
target for hazardous drinking. The recommended first-line insomnia treatment - cognitive behavioral therapy for
insomnia (CBT-I) - holds promise as a therapy that may reduce alcohol use via improved sleep. CBT-I trained
practitioners, however, are rare, and the multiple required visits may not be covered by insurance. One solution
to these obstacles is the implementation of efficacious, accessible electronic cognitive behavioral therapy for
insomnia (e-CBT-I). For this project, we will utilize Sleep Healthy Using the Internet (SHUTi), the most widely
used and well-validated version of e-CBT-I, in a sample of heavy drinking, community dwelling adults with
insomnia. We have exciting preliminary data showing that SHUTi improves sleep and reduces alcohol
consumption in this population. Here we will extend these findings by conducting a well-powered randomized
controlled trial. We will utilize a two-arm, single blinded, randomized control, mixed methods design. For the
active treatment condition (n=50) participants will have 9 weeks to complete the 6-week SHUTi program. In the
control condition (n=50), participants will have access to a web-based sleep education program for the same
time period. Both programs will be accessed through the Internet and will contain information about sleep and
sleep hygiene; only the SHUTi group will receive feedback and targeted recommendations based on sleep
diary data. Alcohol use, insomnia severity, and sleep quality will be quantitatively assessed via online survey
and sleep and alcohol use diaries at baseline and three time points: T1 (at the end of the 9-week intervention
period), T2 (3-months post-intervention), and T3 (6 months post-intervention). All participants will additionally
take part in semi-structured qualitative interviews at T1. Our central hypothesis is that SHUTi will reduce
alcohol use via improved sleep in this population, and that effects will be more pronounced in women. This
project will be the first to test SHUTi in community dwelling, heavy drinking adults with insomnia. If successful,
our intervention will provide an easily-accessible, cost effective intervention for a high-risk population, and
holds potential for positive public health impact, especially for women.

Public health relevance
Alcohol use disorder (AUD) is an urgent and escalating public health problem estimated to cost the United States $249 billion per year. Insomnia, a public health crisis in its own right, often precedes problematic drinking, thus treating insomnia may serve as a novel prevention target for AUD. Our innovative, mixed methods project will be among the first to test a technologically-facilitated, non-pharmaceutical insomnia intervention to reduce alcohol consumption in heavy-drinking, community dwelling adults with insomnia.